COMPARISON OF THE ACUTE RESPONSES TO LEUPROLIDE ACETATE AND NAFARELIN ACETATE

Lupron will be administered to normal and hyperandrogenic women who have previously undergone nafarelin testing. Three different doses will be evaluated in a randomized, double-blind design.